Dissecting the Molecular Mechanisms of NLRP3 Inflammasome Activation and Regulation.

Abstract
This research proposal aims to elucidate the mechanisms underlying the activation and regulation of the NLRP3
inflammasome, focusing on conformational changes, post-translational modifications (PTMs) such as ubiquitination
and lipidation, and novel regulatory factors. These regulatory mechanisms ensure precise activation and prevent
excessive inflammation that could lead to tissue damage or chronic inflammatory diseases. By understanding these
regulatory processes, we can gain valuable insights into NLRP3 biology and its role in various diseases, ultimately
aiding in the development of targeted therapies for inflammatory and autoimmune conditions.
Significant progress has already been made towards these aims, including high-resolution cryo-EM map and
identification of novel regulators through mass spectrometry. My preliminary data have already revealed new
conformational states of NLRP3, and identified specific ubiquitination and lipidation sites on NLRP3 that may be
crucial for its activation. The K99 phase will focus on improving the resolution of my cryo-EM maps, verifying PTM
sites, and determining the functional roles of these modifications.
In the R00 phase, I plan to explore the roles of novel regulatory proteins in NLRP3 activation. Using mass
spectrometry and protein interaction studies, I will identify and characterize new regulators that interact with NLRP3
in a temporal and spatial manner. TurboID technology will be employed to map the interactome of NLRP3 during
different stages of activation, providing a comprehensive understanding of the dynamic changes in protein
interactions. I will determine the cryo-EM structures of NLRP3 in complex with these identified regulators to reveal
their mechanisms of action.
My long-term interest lies in understanding immune responses following pathogen infection, both in health and
disease. With the experience gained from a K99/R00 Award, I aim to establish an independent laboratory dedicated
to basic and translational research on inflammasome activation, control, degradation, and its interaction with
pathogens. This research will provide a solid foundation for developing novel therapeutic strategies to modulate
inflammasome activity, offering new hope for patients suffering from chronic inflammatory and autoimmune diseases.

Public health relevance
Specific Aims This project aims to elucidate the structural mechanisms of NLRP3 inflammasome activation, a critical component in innate immunity implicated in various inflammatory and autoimmune diseases. By employing advanced cryo-electron microscopy and single-molecule imaging, we will investigate the conformational states of NLRP3, identify key post-translational modifications, and explore the dynamics of its interaction with binding partners. This research will provide crucial insights into the molecular basis of NLRP3 regulation, facilitating the development of targeted therapies for conditions such as cryopyrin-associated periodic syndromes (CAPS), gout, and type 2 diabetes.